Vascular Biology 2024 - Annual Meeting of the North American Vascular Biology Organization

Vascular Biology 2024
Annual Meeting of the North American Vascular Biology Organization
Organizers: Alejandro Adam and Gabrielle Fredman (Albany Medical Center), Miranda Good* (Tufts
University School of Medicine), Stefania Nicoli (Yale School of Medicine), Sara Nunes de Vasconcelos
(University of Toronto), Beth Roman (University of Pittsburgh), Joseph Rutkowski (Texas A&M University),
Arndt Siekmann (University of Pennsylvania), Amber Stratman (Washington University in St. Louis), and Ying
Zheng (University of Washington)
October 20-24, 2024
Asilomar Conference Grounds, Pacific Grove, California
Principal Investigator: Ying Zheng
Project Summary/Abstract
The vascular biology field is undergoing a transformation as new technological developments and discoveries
are revealing the extent and mechanisms of vascular diversity. Vascular biologists have a growing appreciation
for how vessel structure and function can vary in different organs, developmental stages, sexes, and disease
contexts and how this variation can impact therapeutic strategies for tackling a wide range of pathologies. Two
important factors that contribute to vascular diversity are (1) the genetic patterning of developing vessels, and
(2) the surrounding environment in which vessels grow and adapt. Vascular Biology 2024 (VB2024) will
provide a forum for in-depth exploration of these factors by covering the themes of (1) development and
genetics, (2) matrix biology and bioengineering, (3) signaling and (4) inflammation. The combination of these
four themes fosters exciting opportunities for vascular biologists with diverse expertise to collaborate and make
discoveries. In addition, VB2024 will host the Microcirculatory Society (MCS) as its guest. The MCS brings
classical expertise in microcirculatory physiology and function, and benefits the molecular, genetic, and
bioengineering approaches of NAVBO meeting participants, and vice versa. Overall, VB2024 aims to bring
together scientists focused on developmental, genetic, matrix, bioengineering, signaling, inflammation and
microcirculatory aspects of the vasculature so that their cross-fertilization can progress the field's
understanding of vascular development, diversity, and therapeutic potential.
VB2024 will be an international meeting that draws researchers from academia, industry, and government and
incorporates both trainees and established scientists. The meeting will be held at the Asilomar Conference
Grounds, from October 20-24, 2024. The roster of organizers and invited speakers provides a diverse and
inclusive face to the meeting, with women, junior faculty, and individuals from underrepresented groups
featured. In addition, a large number of speakers will be selected from abstract submissions to give trainees
and junior faculty additional opportunities to present their research and to promote diverse voices. The meeting
will include 14 concurrent sessions across the five main topics and two cross-over themes on malformations
and mechanotransduction. Keynote, NAVBO and MCS award lectures and the sessions on Metabolism,
Vascular Malformations, and Microvascular Changes During Pregnancy are general sessions that will unify all
meeting participants in one room. Additional opportunities for formal and informal interactions will occur at
poster sessions, group meals, nano-talks, and a conference-wide reception on opening night. Altogether,
VB2024 will serve as a nexus for scientists of diverse career stages, backgrounds, and perspectives to come
together for four days of intensive discussion and interaction that will foster new ideas and collaborations to
advance the field of vascular biology and will highlight potential areas of therapeutic opportunities to promote
the NHLBI mission.

Public health relevance
Vascular Biology 2024 Annual Meeting of the North American Vascular Biology Organization with guest society: Microcirculatory Society October 20-2419, 2024 Asilomar Conference Grounds, Pacific Grove, California Principal Investigator: Ying Zheng Project Narrative: At this vascular biology meeting, scientists will present new discoveries in developmental vascular biology, microcirculation, matrix biology, bioengineering, vascular genetics, vascular signaling, and inflammation and will openly discuss the impact of their findings on development, health, and disease. The integrated topics and participation by the Microcirculatory Society will facilitate interactions between established researchers and trainees with overarching common interests, who might otherwise not have opportunities for direct interaction and scientific exchange. Moreover, the conference will provide a forum for dialogue between basic and clinical/translational researchers, thereby stimulating discussions and innovations about how to optimize therapeutic approaches for the treatment of vascular pathologies.